Mechanisms of stepwise activation and drug-modulation in ligand-gated ion channels.

PROJECT SUMMARY
Activation of ion channels upon binding multiple ligands at distinct subunits or domains is essential for synaptic
transmission and cellular signaling. Despite recent advances in understanding their 3-dimensional structure,
there remains for many channels a fundamental gap in our understanding of the sequence of events by which
multiple binding sites and domains coordinate to open and close the channel pore. A major barrier to bridging
this gap is that ensemble-averaged binding measures from many channels at once occlude observation of the
distinct asynchronous binding steps that underlie the sequence of binding events at each individual channel. To
overcome this barrier, I will use innovative single-molecule fluorescence methods developed in my lab in
combination with my prior expertise with zero-mode waveguide nanophotonic arrays that enable optical tracking
of each individual binding step. The objective of this proposal is to determine the energy landscape for 1) the
sequence of stepwise binding events that drive activation of cyclic nucleotide gated (CNG) channels critical for
visual and olfactory sensation, and 2) modulation of GABAA receptors by benzodiazepines (BZDs), one of the
most widely prescribed psychotropic drugs today. The rationale is that optical tracking of individual binding
events that are the chemical stimuli by which these channels operate will enable determination of the sequence
of distinct energetic events that must at least partially occur prior to pore opening and thus are difficult to measure
with electrophysiological approaches. The specific aims will: 1) Establish the energy landscape for sequential
binding at a CNG channel; 2) Quantify the likelihood of CNG channel opening with each distinct binding step,
which will test existing disparate model predictions; 3) Develop a mechanistic model for CNG channel activation
that accounts for each distinct binding step; 4) Determine the energy landscape for BZD-binding or sequential
agonist binding at GABAA receptors, and 5) Establish whether or not BZDs alter distinct agonist binding steps.
The proposed research is significant because it will provide a necessary foundation for understanding the
dynamic sequence of events governing ligand-driven behavior in these channels, which currently remain only
poorly understood. The results will have an immediate positive impact as a quantitative benchmark for
computational, structural, and functional studies aimed at uncovering the physical basis for the observed
changes in energy. Ultimately, understanding the full sequence of events during channel activation is essential
not only to advance our fundamental knowledge of ion channel mechanisms, but also to facilitate development
of therapies targeting distinct steps in the activation pathway. Long-term, this knowledge will enable the rational
design of new therapies to improve treatment outcomes and quality of life.

Public health relevance
PROJECT NARRATIVE For many ion channels activated by binding of multiple ligands at distinct domains, the sequence of binding events that drive gating of the central ion conducting pore are difficult to observe as they are obscured by averaging over asynchronous events in ensemble measures, challenge structural identification due to their transient nature, and often precede opening of the channel pore and thus do not elicit ionic currents. This project will employ an innovative combination of single-molecule and fluorescence imaging techniques that can resolve individual binding events and parse out the energy landscape governing the dynamic behavior and coordination of multiple binding sites for both agonists and drugs. The proposed work will fill a critical gap in our understanding of the sequence of energetic events during activation of cyclic nucleotide gated channels essential for visual and olfactory sensation, and resolve a long standing debate on the basis for drug modulation of GABAA receptors by benzodiazepines, one of the most widely prescribed class of psychotropic drugs today.